Non-Invasive Imaging of Ameloblastomas

Aggressive odontogenic neoplasms, including ameloblastomas, demonstrate locally aggressive and destructive
behavior, primarily in the posterior mandible. There are currently no biomarkers or diagnostic strategies for these
tumors beyond standard biopsy. This makes it difficult to accurately determine the resection margins, resulting
in high rates of residual disease and recurrence. Our long-term goal is to provide non-invasive biomarker-based
imaging of ameloblastomas by precisely labeling tumor tissue. This will make it possible to assess tumor margins
either pre- or intraoperatively, allowing clinicians to provide better care for their patients. The overarching goal
of this proposal is to determine the sensitivity and specificity of a labeled epidermal growth factor receptor
(EGFR) antibody, panitumumab, for ameloblastoma tissue and to use it in vivo to image tumor in preclinical
models of ameloblastoma. Previously, research on ameloblastoma has been hindered by the lack of in vivo
models. To address this gap, in collaboration with oral surgeons, we have developed primary patient-derived
xenograft models of ameloblastoma. We demonstrated that fluorescently-labeled anti-EGFR, cetuximab-
IRDye800, could specifically identify tumor tissue in vivo. However, it is currently unknown whether fluorescent
imaging is sufficient to detect tumor within bone. Two hypothesis-driven specific aims will be investigated as
follows: (1) To determine the in vivo sensitivity and specificity of panitumumab-IRDye800 and 89Zr-panitumumab
for human ameloblastoma patient-derived xenografts (PDX). We hypothesize that panitumumab-IRDye800 and
89Zr-panitumumab will have higher sensitivity and specificity for ameloblastoma tumor tissue compared to
controls. (2) To determine the clinical validity of panitumumab-IRDye800- and 89Zr-panitumumab-based imaging
for the surgical removal of tumors using intraosseous models of ameloblastoma. We hypothesize that both
panitumumab-IRDye800 and 89Zr-panitumumab will specifically localize to ameloblastomas and allow accurate
margin determination and surgical removal of tumors. We utilize a new intraosseous orthotopic animal model
and novel imaging probes to non-invasively image, stratify and guide surgical resection in ameloblastomas.
PET/CT imaging of novel radiopharmaceutical, 89Zr-panitumumab, provides a three-dimensional preoperative
evaluation of tumor location, heterogeneity of EGFR expression, and extension in to the jaw, while panitumumab-
IRDye800 provides a corresponding yet complimentary approach for intraoperative margin assessment. The
assembled research team is ideal to address for this work in terms of experience, expertise, access and state-
of-the-art imaging agents and facilities. This project has the potential to develop a method to accurately image
ameloblastomas, and provides a tool for assessing bone invasion in a patient population that is vastly under-
represented in the existing research. These imaging strategies will make it possible to non-invasively and
accurately image tumors to determine the area of resection in order to obtain clear margins, while also reducing
the resection of healthy tissue. Thus, this research has the potential to directly impact patient care.

Public health relevance
PROJECT NARRATIVE: Ameloblastomas are locally aggressive and destructive tumors that invade the jaw bone and require extensive surgeries. At present, there are no biomarkers available for this tumor type, and no diagnostic strategies beyond standard biopsy. This proposal uses labelled antibodies to accurately determine tumor margins with non-invasive imaging, which could result in the preservation of healthy tissue and improve long-term outcomes for patients.